Developing a culturally tailored mHealth symptom monitoring intervention to improve adherence to endocrine therapy among Black women with breast cancer

PROJECT SUMMARY
Candidate Goals. My career goal is to reduce breast cancer health disparities in outcomes by addressing
cancer care delivery issues in minority cancer populations. I received a solid foundation in observational
epidemiological methods which I have applied to cancer survivorship research, but my training has not
provided the skills I need to develop mHealth behavioral interventions or culturally-tailor and test behavioral
interventions. The K08 provides an ideal opportunity to develop the necessary skills to achieve my long-term
career goal as an independent clinical scientist.
Candidate Career Development Plan. In this application, I propose training to develop the skills necessary to
become a leader in the field of developing mHealth behavioral interventions for medication adherence and
other cancer care delivery issues in minority cancer survivors. Training will be obtained through participation in
scientific conferences, methods workshop, coursework, and structed mentorship from experts in developing
culturally tailored behavioral interventions (Dr. Clement Gwede), adherence to endocrine therapy among
patients with breast cancer (Dr. Dawn Hershman), mHealth methodology (Dr. Brian Gonzalez), randomized
clinical trials of behavioral interventions (Dr. Heather Jim), recruitment and retention of minority participants to
clinical studies (Dr. Susan Vadaparampil), and Biospecimen quality and testing (Dr. Shelley Tworoger). This
training will ensure that I achieve my short-term goals after which I will be uniquely positioned to bridge gaps
across disciplines, including: 1) Clinical breast cancer care, 2) Behavioral intervention development, cultural
tailoring, and testing, and 3) Using mobile health technologies and biologic specimens in studies among
vulnerable populations.
Institutional Environment. The research environment, facilities, and resources at Moffitt Cancer Center are
ideal for career development and I have the full support of my Department Chair, Dr. Czerniecki and Associate
Center Director of the Division of Population Sciences, Dr. Shelley Tworoger.
Research Plan. We propose an iterative approach to develop and pilot test a new mHealth behavioral
intervention for AET adherence that is culturally tailored to Black breast cancer survivors. We will first use
qualitative methods informed by Black breast cancer survivors to develop a blueprint of the intervention (Aim
1). We will then iteratively refine and culturally tailor the mHealth intervention focusing on symptom monitoring
and management (Aim 2). Lastly, we will test the intervention for acceptability, feasibility, and preliminary
efficacy (Aim 3). This project will address quality of life (symptom burden) and care delivery (medication
adherence) issues in a health disparity population.

Public health relevance
PROJECT NARRATIVE Almost two-thirds of breast cancers are the hormone-receptor positive subtype which are treated with adjuvant endocrine therapy (AET), yet up to 50% of patients do not take these medications as prescribed resulting with increased rates of breast cancer recurrence and death. Adherence to AET is lower among Black breast cancer survivors and this new mHealth, intervention will address a major barrier to AET adherence, symptoms from AET, in a tailored fashion to Black breast cancer survivors. This intervention has great promise for reducing cancer-related symptoms burden which negatively impact quality of life, reducing disparities in care, and potentially improving cancer outcomes among Black breast cancer survivors.